Oral commensal fungi and structural immunity

PROJECT SUMMARY
While the fungus Candida albicans has largely been studied as a pathogen, its primary lifestyle is as a
commensal on mucosal surfaces, including the oral cavity. Microorganisms that occupy mucosal surfaces are
critical for appropriately tuning immune responses to ensure efficient responses to invading pathogens while
limiting responses directed towards host tissues. In this context, commensal fungi play important roles in host
immunity and inflammation. For instance, C. albicans colonization induces cross-reactive T cells and innate
memory in immune cells, a mechanism termed trained immunity. Accumulating evidence from our group and
others have convincingly demonstrated that oral commensal colonization with C. albicans induces specific
immune responses, therefore contributing to mucosal immune system plasticity. However, the fundamental
immunological consequences of oral C. albicans colonization are still not well understood. Host tissues maintain
traces or memory after microorganism encounter that extend beyond adaptive responses of T and B cells. These
changes include profound structural remodeling and epigenetic alterations. ‘Structural immunity’, the immune
response within a tissue framework created by structural cells, such as endothelial and epithelial cells, is
essential for maintaining tolerance and the development of appropriate protective and controlled immune
responses. In probing for structural processes that maintain effective mucosal immunity in the oral cavity, we
identified two mechanisms which are tuned during oral commensal C. albicans colonization, oral epithelial
proliferation and angiogenesis. Our central hypothesis is that commensal C. albicans exposure in the oral cavity
establishes mucosal ‘structural immunity’ by inducing oral epithelial trained immunity, epithelial remodeling, and
angiogenesis. These tissue remodeling and innate priming events serve to maintain effective mucosal immunity,
thus preventing oral fungal outgrowth of this important commensal organism. This proposal will evaluate the
molecular mechanisms by which oral commensal C. albicans induce epithelial proliferation (Aim 1), and
angiogenesis (Aim1 and 2). In Aim1 we will delineate the role of IL-22 in mediating oral structural immunity in
response to commensal C. albicans colonization. In Aim 2 we will determine the role of VEGF as a mediator of
trained and structural immunity in the oral cavity.

Public health relevance
NARRATIVE Oral candidiasis, also known as oral thrush, is an AIDS-defining fungal infection of the oral mucosa. This disease also afflicts individuals on chemotherapy, transplant patients taking immunosuppressive drugs, asthma patients using inhaled corticosteroid drugs or others with compromised immune function such as infants and the elderly. The objective of this project is to understand interactions between commensal Candida albicans and the host immune system while the long-term goal of this research is to develop better therapies or vaccines for mucosal disease of the oral cavity, and to understand the consequences of therapies that suppress specific immune events.